Somatostatin Receptor 2 Expression in Pituitary Neuroendocrine Tumors as a Basis for PET/MRI guided Subtype Stratification and Radiotherapy Planning

Abstract:
Pituitary neuroendocrine tumors (pitNET), also known as pituitary adenomas, represent 15% of all intracranial
tumors diagnosed in the United States. Postoperative MRI can underestimate residual disease extent due to
postsurgical changes such as disruption of tissue planes, autologous bone and fat grafts, and free mucosal
flaps. Patients with hormone-producing pitNET who are not cured with surgery may be treated medically or
with radiation therapy (RT), most commonly stereotactic radiosurgery (SRS). Suppressive therapy requires
lifelong administration of often-expensive medications that may have substantial off-target side effects. RT will
stop the growth of residual pitNET, but only achieves long-term biochemical remission in approximately 50% of
patients at 10 years. While stereotactic radiosurgery (SRS) can be more effective, MRI-based SRS that does
not treat all of the residual pitNET will fail to control tumor growth and hypersecretion. PitNET express
somatostatin receptor 2 (SSTR2), however the expected range of SSTR2 density and factors influencing
SSTR2 expression in pitNET are not well understood. SSTR2 can be targeted with [68Ga] DOTATATE, a
clinically approved PET radiotracer. Our team has pioneered a dynamic [68Ga]-DOTATATE brain PET/MRI
acquisition protocol, allowing differentiation of SSTR2-positive brain and skull base neoplasms, most notably
meningioma, from post-surgical and post-RT change, using SUV analysis and Patlak modeling. Given our
extensive experience in clinical translation of DOTATATE PET/MRI in SSTR2-positive brain tumors, we are
uniquely positioned to translate this approach in patients with pitNET. DOTATATE PET/MRI has the potential
to improve diagnostic accuracy, increase our understanding of pitNET biology, and improve SRS targeting,
thereby increasing local control and biochemical remission rates in pitNET. Our preliminary findings suggest
that DOTATATE PET/MRI-based extent delineation, particularly of the extrasellar component, may improve
radiosurgical targeting and treatment success in pitNET. However, present knowledge regarding DOTATATE
PET utility in pitNET is limited. We will characterize the range of DOTATATE PET SUV in the context of
clinical, demographic, and endocrine variables. We will compare PET- and MRI-guided RT planning, and
evaluate the potential of PET/MRI to local control and endocrine remission rates relative to MRI-based
literature benchmarks and relative to a separate MRI-based prospective institutional observational control
cohort. We will determine distribution of DOTATATE PET SUV in subtotally resected pitNET, examine
association with demographic variables and hormonal lineage, and compare PET/MRI- to MRI-based tumor
extent delineation. We will further determine short- and intermediate-term clinical outcomes of DOTATATE
PET/MRI guided SRS for residual/ recurrent pitNET. Our proposed study has the potential of improving clinical
outcomes in patients with pitNET by increasing diagnostic accuracy and improving extent delineation of
extrasellar disease, which will optimize radiation targeting thereby achieving greater local control and higher
endocrine remission rates.

Public health relevance
Narrative: The proposed research will improve diagnosis and postoperative treatment planning in pituitary neuroendocrine tumors (pitNET), also known as pituitary adenomas, through the incorporation of targeted PET imaging using [68Ga]-DOTATATE PET/MRI. The proposed research will thus benefit efforts to improve clinical outcomes in pitNET. The proposed research is aligned with the NCI's mission focused on advancing cancer diagnosis and treatment planning, thereby reducing societal burden, focusing on pitNET which are amongst the most common primary brain neoplasms.